Career Enhancement Program

Modified Project Summary/Abstract Section
The Career Enhancement Program (CEP) of the Ovarian Cancer SPORE intends to attract and stimulate new
investigators to carry out translational research related to ovarian cancer and provide mentorship. The program
co-directors, Dr. Drapkin and Dr. Shih, will solicit applications and coordinate selection process. Candidates
apply and are evaluated through a careful selection process involving a career enhancement committee as well as
the SPORE steering committee. The recipients will be required to present their progress twice a year and submit
annual progress report subject to the aforementioned review process. In addition to the requested funding
($50,000) from the SPORE program, a total annual matching fund of $150,000 will be provided by the Sidney
Kimmel Comprehensive Cancer Center at Johns Hopkins and the Department of Gynecology/Obstetrics at
University of Pennsylvania. Those supports allow us to fund 2-3 career awards at funding levels of $50,000 to
$100,000 each year. It is expected that the CEP will play an important role in the recruitment and development
of a cadre of outstanding translational scientists and future leaders in the ovarian cancer research field. At the
same time, these new investigators will bring their own unique expertise and innovations to this Ovarian Cancer
SPORE program.
Specific Goals
• To attract, select, and mentor promising new investigators engaged in ovarian cancer research.
• To develop and support the awardee’s rigorous and innovative translational research projects focusing on
various topics related to ovarian cancer.

Public health relevance
Modified Public Health Relevance Section The relevance of this Career Enhancement Program to public health includes 1) enhancement of awareness, early detection, and prevention in ovarian cancer among population, 2) engagement of new investigators who will devote their research and career in understanding the etiology of this disease.